Transport and Insertion of Outer Membrane Proteins

The envelope of Gram-negative bacteria consists of two membranes separated by the periplasmic compartment that contains the peptidoglycan wall. The inner membrane (IM) is in contact with the cytosol while the outer membrane (OM) contacts the extracellular environment. The OM is a unique structure, essential for Gram-negative bacteria, composed of lipopolysaccharide ([PS), phospholipids and proteins. It is a very selective permeability barrier that allows the bacteria to survive in hostile environments such as the gut, where the OM resistance to bile salts allows enteric bacteria to thrive. The components of the OM are the first to come in contact with a host upon infection and strongly modulate the interaction of symbiotic and pathogenic bacteria with their host. A clear grasp of the OM biogenesis process is essential to understand host-pathogen interactions as well as a fundamental aspect of bacterial physiology. Outer membrane proteins (OMPs) are integral membrane proteins, with 13-barrel structures embedded in the OM. Many OMPs are immunogenic and some of them serve as adhesins mediating adhesion and colonization of host tissues. OMPs are synthesized in the cytosol and translocated across the IM by the SEC translocation machinery However, how these hydrophobic proteins cross the periplasm and insert specifically into the OM is poorly understood. A number of periplasmic proteins and one OMP (0mp85/YaeT) have been implicated in the transport and insertion of OMPs. In this proposal we will determine the structure and substrate specificity of the YaeT complex components as a first step toward understanding the mechanisms of OMP transport and assembly. A combination of crystallographic, NMR and biochemical approaches will be combined to characterize this crucial protein complex.